Organoid and Minibioreactor Array Cultivation Core

Project Summary
The goal of this U19 Genomic Center for Infectious Disease (GCID) application is to use state-of-the-art model
systems to address gaps in knowledge surrounding the genomics of multiple NIAID Category A-C bacterial, viral,
fungal, and parasitic mucosal pathogens. The Organoid and Minibioreactor Array Cultivation (OMAC) core will
assist in achieving this goal by (1) generating, maintaining, and providing experimentally ready and customized
intestinal and airway organoid cultures for the individual projects, (2) providing complex microbial communities
from the intestine and airway customized for use by individual projects in experiments exploring how the
microbiome affects pathogenesis, and (3) developing new tools, models, and platforms for use by the individual
projects to explore additional aspects of intestinal and airway biology that may affect infectious disease
pathogenesis. The centralization of these activities in the OMAC core allows the provision of critical biologically
relevant human organotypic and bacterial cultures that are essential for the success of the project and ensures
standardization and reproducibility. These reagents will facilitate the translation of genomic analysis by validation
of key outcomes. Centralization will also result in a reduction in labor, supplies, and equipment costs ultimately
resulting in time and cost savings for the overall center. Due to the use of the core by all Center projects, the
core stands as a central unifying element that connects the projects. As a result, the OMAC core will enhance
interproject communication and enable the comparison of center wide results. The establishment of the OMAC
core will be an essential aspect of the success of the Center.